Task A67: Assessment of the Pharmacokinetics and Efficacy of Therapeutics Against Tuberculosis (TB)

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.